Natural Plasma Nano-EVs for Drug Delivery

ABSTRACT
Targeted delivery of efficacious drug levels with minimal off-target effects remains a major pharmacological
challenge as exemplified by the poor delivery of proteins, antisense oligonucleotides (ASO), and other
therapeutics to may organs. Drug delivery platforms that allow for controlled pharmacokinetic profile and cell
targeting, including nanoparticles, liposomes and cell-derived extracellular vesicles (EV), are thus aggressively
pursued by biopharma. However, several key gaps remain in engineering the appropriate size and surface
composition of drug carrier nanoparticles, which dictates their biodistribution. Despite their favorable
immunogenicity profile, EVs generated from human stem cells or immortalized cell lines invariably show
entrapment by reticuloendothelial (RES) cells in liver, spleen, and bone marrow following intravenous (IV)
dosing. In contrast, the persistently high plasma level of endogenous, organ derived EVs likely reflects reduced
clearance and longer circulation times, both properties important for allowing for efficient payload delivery to
multiple target tissues. Also, surface molecular signatures comprised of exposed proteins and lipids, which vary
across plasma EV subsets, are likely to dictate their tropism to specific organs or cells. This research will
capitalize on the naturally engineered properties of endogenous EVs to develop the first human plasma derived
drug delivery product.
We have developed a novel and sensitive multiplexed immunoassay, suitable for the use with unprocessed
plasma, to characterize plasma EV subsets based on specific profiles of surface-exposed proteins. This method
enabled us to discover of a novel endogenous subset of nano-EVs (nEV), whose small diameter (10-40 nm)
contrasts sharply with the 50-200 nm diameter reported for most EVs. The nEVs contain protein and RNA
markers of cells representing several organs as well as surface lipid and protein features to reduce RES clearance.
We hypothesize that this newly discovered EV subset is naturally adapted for long-range inter-
organ communications, and thus ideally suited for drug delivery.
This project will develop a robust and scalable method for isolation of large amounts of nEVs from commercially
acquired human plasma. We will also quantitatively characterize in vivo nEVs PK and biodistribution using in
vivo positron emission tomography (PET) and fluorescence imaging. The following specific aims will be pursued
in the current proposal: Aim 1: Nano-EV production: scale-up and characterization. Aim 2: Analysis of nEV
biodistribution and plasma half-life. By demonstrating that nEVs have improved biodistribution properties over
traditional EVs and that they can be easily isolated in large amounts from human plasma then phase 2 of our
SBIR will focus on optimizing drug loading and demonstrating efficacy in disease models.

Public health relevance
NARRATIVE Extracellular vesicles (EVs) are membrane-bound nanoparticles released by all cell types that transfer proteins and RNA between cells and tissues; however, most attempts to implement EVs for drug delivery utilized production in cell culture and show no significant improvement over artificial liposomes, likely due to low representation of EV subpopulation suitable for long-range transport. Here we propose drug delivery using plasma EVs, specifically a newly identified smaller plasma nanoEVs, which offer potential advantages due to improved safety, biodistribution and potential brain penetration.